Mechanisms and functions of ATP-dependent chromatin remodeling

[unreadable] DESCRIPTION (provided by applicant): The broad, long-term goals of the proposed studies are to determine how chromatin structure affects nuclear processes, and how chromatin structure is regulated to accommodate these processes. These are fundamental questions because chromatin regulation affects virtually every biological process that take place in nucleus, including transcription, recombination, DNA repair and DNA replication. Consistent with their importance in understanding chromatin regulation, mutations in numerous chromatin regulators have been linked to human diseases, including cancer. Therefore, studying chromatin regulation will contribute not only to further identification of mechanisms governing basic biological processes, but also to understanding the molecular basis for human diseases. In our previous work, we found that a chromatin regulator Isw2 plays critical roles in both suppression of non-coding transcription and facilitation of DNA replication in our model system, budding yeast Saccharomyces cerevisiae. To elucidate mechanisms and functions of this intriguing chromatin regulator further, we will take multidisciplinary, complementary approaches. We will test our hypothesis that a major role of Isw2 is to be targeted to the ends of genes via a previously unidentified mechanism to protect the genome from abnormal non-coding transcription. In a parallel effort, we will investigate how this complex facilitates DNA replication using molecular genetic approaches. It has become clear that mutations in the human genome that cause abnormal chromatin regulation cause numerous human diseases, including cancer. Our proposed studies elucidate how major regulators of chromatin structure function in cells, contributing to a better understanding of the molecular basis for human diseases. [unreadable] [unreadable] [unreadable]